Investigating GWAS-nominated risk genes associated with Parkinson's disease using a CRISPR-based toolkit

ABSTRACT
Parkinson's Disease (PD) is an age-related progressive neurodegenerative disorder primarily characterized by
the loss of dopamine (DA) neurons in the midbrain, which is crucial for motor control and balance. Current
treatments, such as L-DOPA and deep brain stimulation, provide symptomatic relief but crucially, do not halt
the progression of neurodegeneration. While familial PD cases have highlighted mutations in approximately 20
genes, the majority of PD cases are sporadic, likely resulting from complex interactions between aging,
genetics, epigenetics, and environmental factors. Recent Genome Wide Association Studies have identified 90
risk loci and 305 nearby candidate genes that might have a significant genetic component to sporadic PD,
however, the specific roles of these genes in PD pathophysiology remain to be confirmed and elucidated
biologically.
In this proposal, I will investigate the hypothesis that one of these genes, CTSB, plays a critical role in PD.
CTSB encodes cathepsin B, a lysosomal enzyme implicated in various neurological disorders, with evidence
suggesting its downregulation may be associated with PD. I will utilize a CRISPR-based functional toolkit in
mouse models to downregulate Ctsb specifically in DA neurons and examine its effects on neuronal survival,
morphology, physiology, and behavior over time. To achieve this, I will employ a Cre-dependent dCas9-KRAB
(CRISPRi) system in combination with a DAT-IRES-Cre mouse line, allowing for targeted downregulation of
Ctsb in midbrain DA neurons via intracranial injection of a Ctsb sgRNA compared to a scrambled non-targeting
control sgRNA. I have already shown co-localization of Ctsb and Th mRNA in midbrain DA neurons and
successful Ctsb downregulation in primary neuronal cultures. This study aims to determine whether Ctsb
downregulation reveals cell autonomous alterations in dopaminergic neuronal function and behavior at 3, 6,
and 12 months of age. These experiments will provide insights into the role of Ctsb in sporadic PD, potentially
identifying it as a true risk gene. Understanding how Ctsb affects DA neurons may lead to the development of
treatments that address the underlying pathology of PD, offering a significant advancement over current
therapies that primarily manage symptoms without altering disease progression.

Public health relevance
PROJECT NARRATIVE Parkinson’s Disease (PD) is the second most common neurodegenerative disorder, primarily characterized by the progressive loss of dopamine neurons in the midbrain, leading to motor symptoms such as tremors and impaired balance. The proposed research aims to investigate the role of the gene CTSB, which encodes a lysosomal enzyme involved in proteolysis, in PD by downregulating its expression in dopaminergic neurons using a targeted CRISPRi approach. This research will inform therapeutic development, as understanding CTSB's impact on PD could lead to novel strategies to prevent or reverse neurodegeneration.